Training in Pharmacological Sciences

Project Abstract:
We seek eight training slots to support students during their first and/or second year of training in
pharmacological sciences. The Therapeutics Graduate Program (TGP) recruits students from multiple Harvard
PhD programs to build a diverse and inclusive community focused on therapeutic science, with a strong focus
on professional skills development and career mentoring. The TGP provides rigorous training in the science of
drug discovery, evaluation, and clinical use through a required core curriculum, paracurricular activities
focused on professional skills development, and a signature required internship, where students spend 2–4
months in an industrial or regulatory science setting before the end of their 4th year. Recruitment: The TGP
will recruit students and faculty from multiple HMS and Harvard programs, including Biological and Biomedical
Sciences (BBS), Chemical Biology, and Systems Biology graduate programs at Harvard Medical School
(HMS), Harvard University, and the HMS-affiliated teaching hospitals. Faculty will be evaluated for scientific
relevance and mentoring skills, and openness to student-centric training experiences. Diversity/inclusion: We
are committed to building a diverse, inclusive, and supportive training community. Intellectual diversity will
benefit by recruitment from multiple PhD programs. We will boost social and ethnic diversity by emphasizing
how the TGP prepares students for careers with direct societal impact and provides clear and direct career
preparation through internships. Professional skills and career development: We involve industry
professionals in teaching 1st year classes and co-organizing paracurricular activities focused on skills
development. Our required internship experience provides trainees with hands-on exposure to industrial or
regulatory science work environments, and provides strong networking opportunities. Internships also help
mentors understand the benefit of our commitment to student-centric training. Scientific rigor and
responsible conduct: These components are emphasized throughout the curriculum, and reinforced by
mentorships where students are exposed to team-based science in a professional setting. Training benefit:
There is a strong demand for PhD-level scientists who have been rigorously trained in the core concepts of
drug discovery. Demographic trends are increasing the need for drug treatments, and there is optimism for
treating the most feared diseases based on recent progress and emergence of new drug modalities such as
antibodies and oligonucleotides. Many research schools and hospitals are building translational research
centers, often in collaboration with local industry, and these need to recruit faculty and PhD-level staff. The
pharma/biotech industry has exploded in Massachusetts in the last decade, and many PhD-level positions
remain unfilled. TGP trainees will lead in this growing field.

Public health relevance
Project Narrative The Therapeutics Graduate Program (TGP) will train PhD students for academic and industry careers in discovery, evaluation, and clinical use of drugs. This interdisciplinary program will recruit students from multiple Harvard PhD programs to build a diverse and inclusive community focused on therapeutic science, with a strong focus on professional skills development and career mentoring in addition to rigorous science.